Optical measures of cerebral arterial function as predictors of brain and cognitive aging

Cerebrovascular health (and in particular arterial stiffening, or arteriosclerosis) is a significant contributor to age-related
decline, and exerts a central role in a number of pathologies, including Alzheimer's disease (AD) and vascular dementia.
Arteriosclerosis is progressive and considered to be irreversible. Therefore its early detection is of critical importance. As
extensively demonstrated by the Framingham Heart Study and other longitudinal research, life style factors, and in
particular physical inactivity, play a central role in the development of arteriosclerosis. Cerebral arteriosclerosis is
currently assessed either indirectly with peripheral measures or more directly in the neck and head (with carotid or trans-
cranial Doppler sonography, TCD), which provide useful clinical information but at just a few measurement points. Our
lab has recently developed a new imaging approach, based on the study of the arterial pulse measured with diffuse optical
tomography (pulse-DOT), which allows for the mapping of arterial status across the entire cortical mantle, with high
reliability and replicability. We have shown that in normally aging older adults, low values of PReFx (pulse relaxation
function, a measure of pulse shape indicative of arterial elasticity) are correlated with older age, lower cardiorespiratory
fitness (CRF), and overall greater age-related brain atrophy and white matter signal abnormalities (WMSA). Crucially, we
have also shown that local/regional variations in arterial stiffness from one brain region to another correlate with
volumetric variations in the same regions. These regional effects provide a stronger functional link between arterial health
and early structural signs of brain aging than those derived from global measures of arterial elasticity, pointing at the
importance of arterial function in the chain of events that may lead, over time, to cognitive and brain volumetric losses. In
the proposed research, based on a mixed cross-sectional/longitudinal (30 month) design involving 200 individuals
between 50 and 70 years of age, we aim to: (1) Demonstrate that pulse-DOT will relate to cerebrovascular risk cross-
sectionally and also prospectively over a 30-month period. Individuals classified by degree of presence of sub-clinical risk
factors relating to low CRF are expected to show a graded relationship with the PReFx index of arterial stiffness, as well
as with indices of cerebrovascular reactivity (CVR). Decreasing PReFx pulse-DOT values over follow-up are then
expected to predict a worsening of risk. (2) Demonstrate that regional changes (over 30 months) in cerebral arterial
function are associated with regional changes in brain structural (i.e., indicating signs of brain atrophy and WMSA) and
blood flow parameters in the same regions (measured with magnetic resonance imaging, MRI). (3) Identify the
relationship between cognitive function, regional vascular stiffening and CVR at baseline and over the follow-up period.
We anticipate a concordance of regional deficits in vascular stiffening and vascular reactivity that will relate to specific
deficits in cognitive processing. These findings should provide information not only on global effects of variations in
cerebral arterial stiffness on brain and cognitive aging trajectories, but also on the regional profiles of arterial stiffness. In
the long term this approach may provide a tool for studying cerebrovascular effects in basic and clinical applications, and
for guiding individually tailored early interventions, designed to prevent age-related cognitive decline, MCI and AD.

Public health relevance
! Narrative Inactivity and low cardiorespiratory fitness are among the most important risk factors for cerebral arteriosclerosis (stiffening of the arteries), a condition that has long been associated with accelerated cognitive decline in older individuals, with increased risks for mild cognitive impairment (MCI) and dementia. In the proposed research we investigate the use of novel measures of cerebral arterial elasticity (based on optical measures of the cerebral arterial pulse, pulse-DOT), to assess early stages of cerebral arteriosclerosis in normally aging individuals (50-70 years). Pulse- DOT provides maps of arterial stiffness in an individual brain, which may be associated with age-related regional structural brain changes and specific patterns of cognitive decline, and could be used for designing individually tailored interventions for the prevention of MCI and dementia.